Postcensal Estimates of Resident Population for Counties

This effort is to develop the following two sets of estimates of resident population for counties: 1. Vintage 2020 estimates - county population estimates by age group (85-89, 90-94, 95-99, 100+), sex, bridged race, and Hispanic origin for April 1, 2010 (estimates base) and annually July 1, 2010-2020 2. 2000-2010 Intercensal Estimates - county population estimates by age group (85-89, 90-94, 95-99, 100+), sex, bridged race, and Hispanic origin for April 1, 2000; annually July 1, 2000 - July 1, 2009; and April 1, 2010